Collaborative Pediatric Critical Care Research Network - Clinical Site

PROJECT SUMMARY/ABSTRACT – University of Minnesota
The Collaborative Pediatric Critical Care Research Network (CPCCRN) has been critical in building the
knowledge base of pediatric critical care medicine. The overall aim of this site proposal is for the University of
Minnesota Masonic Children's Hospital (UMMCH), under the leadership of Site Principal Investigator, Marie
Steiner, MD, MS, to join this expanded iteration of CPCCRN. UMMCH is a free-standing, quaternary care,
academic children’s hospital located in Minneapolis, MN, serving children and families across a diverse range
of racial, ethnic, and socioeconomic backgrounds. It has a 24-bed mixed medical/surgical and cardiac pediatric
intensive care unit and offers the full spectrum of pediatric and surgical subspecialty services. UMMCH has a
strong history of clinical research and innovation in conjunction with the resources of the University of
Minnesota, the state’s land grant university. Pediatric critical care research includes numerous completed and
ongoing studies championed by multiple faculty, including the Co-Investigators for this grant. With increasing
support from internal and external grants and the development of the Pediatric Device Innovation Center, the
Division was third in the Department in launching new studies in 2019, behind Hematology/Oncology and
HSCT. Children's Minnesota (Children’s) will serve as our Ancillary Site under the leadership of Alberto
Orioles, MD. Children’s is a not-for-profit, freestanding children’s hospital also located in Minneapolis, with a
long-standing history of participation in critical care research, including several CPCCRN studies. Together,
UMMCH and Children's will provide access to 55 pediatric ICU beds and over 3500 annual admissions, which
captures the majority of critically ill children throughout the Upper Midwest and will facilitate participation in
large clinical trials. The proposed “Personalized Immunomodulation in Sepsis-Induced Multiple Organ
Dysfunction Syndrome (MODS)” trial addresses the hypothesis that immunosuppressed children will benefit
from administration of granulocyte macrophage-colony stimulating factor and that children with
hyperinflammation will benefit from targeted anti-inflammatory therapy. Benefit will be evaluated in terms of
recovery from MODS, as well as short- and long-term health-related quality of life measures. This partnership
has the knowledge and skills to successfully complete this trial, including sample collection and processing for
immunophenotyping and collection of short- and long-term outcomes. Drs. Steiner and Orioles have the full
support of their respective institutions to participate in CPCCRN and to prioritize patient recruitment and
accrual to its studies. The institutions are strongly committed to collaboration with CPCCRN sites and the Data
Coordinating Center to conduct the proposed and future research. Our clinical center and ancillary site will
provide local mentorship for our highly talented young faculty and will support their participation in the central
CPCCRN mentoring activities that are described in Section B.3 of the required CPCCRN Network
Organizational Structure attachment to the Overall Component of this PL1 application.

Public health relevance
PROJECT NARRATIVE - University of Minnesota This proposal is relevant to public health because the University of Minnesota Masonic Children's Hospital and our ancillary site, Children's Minnesota, will enroll children from a variety of social, economic, and racial backgrounds from throughout the Upper Midwest to CPCCRN studies. The proposed project investigates the impact of individual immune function profiles and treatment on organ dysfunction from sepsis and whether treated children recover more fully following their illness and therefore requires a diverse patient population to adequately address this personalized question. UMMCH's role as a clinical site is relevant to the NICHD CPCCRN's mission to care for all critically ill and injured children, and to reduce the impact of illness and disability on every child.